Mechanical Regulation of PKA Function in Cell Adhesion and Migration

PROJECT SUMMARY
Cell adhesion to the extracellular matrix (ECM) is fundamentally important to multicellular life. Focal
adhesions (FAs) are the best characterized cellular structures involved in cell-ECM adhesion, and not only serve
as physical couplings but are important centers of signal transduction. While FAs are well- known and well-
characterized for being enriched in tyrosine phosphorylated proteins, the phosphoserine and phosphothreonine
content of FAs is three times higher than phosphotyrosine. Despite this, the kinases that mediate these
modifications and the mechanisms and consequences of their function are poorly understood. We have found
that the cAMP-dependent protein kinase (PKA), a venerable kinase with hundreds of targets throughout the
cellular landscape, is present and active within FAs. Moreover, we have found that PKA binds directly to talin, a
critically important mechanosensitive FA scaffolding protein, in a manner that requires conformational unfolding
of talin. These observations suggest that talin is a mechanically-gated A-kinase anchoring protein (AKAP) that
couples cellular tension to PKA signaling within FAs. Here, we propose to use biophysical, biochemical, and cell
biological approaches to characterize the regulation and function of this new axis of localized
mechanotransduction. We will delineate how (1) molecular and cellular mechanics regulate the PKA-talin
interaction; (2) PKA-mediated phosphorylation regulates the function and interaction of talin, TAPs, and other
FA proteins; (3) disrupting talin-PKA interaction and associated signaling events impact cell adhesion, cell
spreading, and cell migration; and (4) cell adhesion and contractility regulate FA PKA activity. These
investigations will not only reveal new facets of adhesion-dependent signal transduction, but will also identify
FAs as a new, discrete niche for PKA function and establish a paradigm for mechanical regulation of this
ubiquitous kinase that may play a role in other mechanosensitive cellular structures and events.

Public health relevance
PROJECT NARRATIVE Just as a person’s behavior can be influenced by their surroundings, so too can the functions of individual cells be influenced by the cell’s microenvironment. When cells attach to & ‘sample’ this environment – called the extracellular matrix – they form specialized structures called focal adhesions that not only help the cells attach but also report and control the status of that attachment. This project focuses on a powerful ‘reporting’ or signaling protein, called Protein Kinase A (PKA, for short), that we have recently found is active within focal adhesions, and proposes to investigate what keeps it there, what it’s controlling, and what it’s reporting – all with the hope that by learning more about this particular reporter, we will learn more about how cells are influenced by their surroundings.